Regenerative Engineering of Musculoskeletal Tissues- a Convergence Doctoral Training Program

We propose a novel NIAMS doctoral T32 Program, Regenerative Engineering of Musculoskeletal Tissues: A Convergence Doctoral Training Program, which offers interdisciplinary research areas at the University of Connecticut (UConn) combining biomedical science and engineering faculties. Regenerative Engineering is defined as the Convergence of advanced materials science, stem cell science, physics, developmental biology and clinical translation for the regeneration of complex tissues and organ systems. They will all receive their Ph.D. from the Graduate School at UConn. The T32 Program will offer trainees a broad level of expertise in research and instruction based on the research, educational, and clinical experiences of the biomedical and engineering faculty who serve as preceptors. Trainees will become experts in regenerative engineering and its foundations to work towards the alleviation of human disease and musculoskeletal injuries by means of tissue regeneration. Musculoskeletal regeneration is a field ripe for an inventive approach based on convergence to address challenging issues, advance technology and further fundamental knowledge for therapeutic applications. At the center of the Convergence approach is the understanding that new solutions in regeneration will take place through an ‘un-siloed’ approach. Thus, Regenerative Engineering welcomes ideas and research across a gamut of disciplines. The T32 Program has preceptorship commitments from 20 distinguished faculty at UConn (representing Biomedical Engineering, Cell Biology, Computer Science, Genetics and Genome Sciences, Materials Science, Mechanical Engineering, Molecular Biology and Biophysics, Oral Health, Orthopedic Surgery). This eminent group of investigators is well funded and published to provide the primary research training and serve as role models for doctoral trainees. The T32 Program goals are to educate, support and enhance the training of individuals dedicated to careers as independent clinical translational and basic scientists in regenerative engineering. Our Program strengths include its interdisciplinary and collaborative research in biomedical science and engineering, training in contemporary research methodologies, and successful preceptors. T32 Program administration through The Cato T. Laurencin Institute for Regenerative Engineering will provide the experience to recruit talented trainees, implement the curriculum, and train a new cadre of convergence scientists.

Public health relevance
PUBLIC HEALTH RELEVANCE Disorders of the musculoskeletal system with advancing age or due to injury and trauma are among the most debilitating to the human body and costly to the healthcare system with disability. Novel treatments will require convergence of molecular, cellular, and organismic research through interdisciplinary integration of biomedical science and engineering. This T32 Program is based on the unique concept of training Ph.D. candidates in the realm of scientific convergence applied to the field of regenerative engineering to enable these discoveries.